Immunological mechanisms underlying acupuncture analgesia in patients with sickle cell disease

Project Summary
Pain in sickle cell disease (SCD) is a major lifelong complication that disproportionately affects Black and African
American people. Clinically, SCD presents in two distinct phases: the steady-state phase associated with chronic
pain, and the vaso-occlusive crisis (VOC) phase characterized by severe pain which requires high doses of
opioids and is associated with increased risk of overdose and death, opioid-induced hyperalgesia, and lowered
quality of life (QoL). Mechanistic studies directly addressing the pathophysiological mechanisms of transition
from steady-state to VOC are notably limited. Recent studies suggest that the progression of VOC is linked to
abnormal vasoconstriction resulting from dysfunction of the autonomic nervous system (ANS). There is an urgent
need to gain a fundamental understanding of the pathophysiology underlying the transition from pain to VOC
and to develop evidence-based, effective, and safe therapies for managing pain in SCD patients. Preliminary
results from our completed trial (ClinicalTrials.gov Identifier: NCT05045820) suggest that verum acupuncture
treatment improved patient-reported pain, QoL, and reduce opioid requirements and the number of patientreported VOC. However, our understanding of the pathophysiology of SCD and VOC, and the mechanisms by
which acupuncture ameliorates clinical symptoms of SCD, remains very limited. Our recent findings revealed a
complex interplay among dysregulated inflammatory mediators and autoantibodies, and their relationship with
VOC, pain, and sensory sensitivity at baseline in SCD patients. Subsequently, we observed that the reduced
inflammatory markers and improvements of VOC/QoL/opioid requirement outcomes significantly differ between
the verum and sham treatment groups. Leveraging a new clinical trial, we propose to specifically examine the
inflammatory/immune biomarkers related with the onset and progression of VOC and their modulation by
acupuncture through three Aims. Aim 1: Characterize variation in inflammatory/immune profiles in SCD patients
as they progress to VOC. Aim 2: Determine the effect of acupuncture on inflammatory/immune patterns. Aim 3:
Investigate the anti-inflammatory mechanisms of acupuncture. Persistent disparities in healthcare access faced
by African Americans are widely recognized and have clear links to unfavorable health outcomes. If successful,
the proposed studies have the potential to unveil novel mechanistic targets for effectively managing VOC and
advance our understanding of the mechanisms underlying acupuncture analgesia.

Public health relevance
Project Narrative Novel and effective approaches are urgently needed for understanding mechanisms and improving the management of pain at steady phase and vaso-occlusive crisis (VOC) at acute phase in sickle cell disease (SCD). The proposed work investigates inflammatory/immune biomarkers associated with the onset and progression of VOC and acupuncture analgesia using cross-sectional and longitudinal blood samples at both steady and VOC phases. This resulting work fills a void in our understanding of VOC-related inflammatory/immune mechanisms and significantly enhances the implementation of evidence-based integrative care in SCD.